Core 3: Structural Biology and Biophysics (SBB) Core

ABSTRACT
The Structural Biology and Biophysics (SBB) Core will provide Program Project Investigators with high-qual-
ity atomic resolution mapping and quantification of salient protein ligand binding sites using NMR and other
biophysical techniques. The vast majority of proteins involved in DNA homology-directed repair and its regulatory
axis are comprised of significant stretches of intrinsically disordered (ID) residues that serve as ligand interac-
tions sites. With class-leading expertise in the structural and biophysical characterization of ID proteins, the SBB
Core will combine state-of-the-art NMR to map, at atomic resolution, the protein ligand interfaces and nucleic
acid binding sites, thus identifying critical amino acid residues mediating these interactions to guide the devel-
opment of separation of function mutants. By their nature, intrinsically disordered protein ligand complexes are
highly dynamic, transiently populated, and weakly associated, features that preclude high-resolution structure
determination by cryo-EM or X-ray crystallography. The approaches, techniques, and overall expertise available
within the SBB Core circumvent these technical limitations to assist Program Project investigators in defining
crucial ligand interaction interfaces at atomic resolution. Our biophysical and structural biology wherewithal will
furnish insights for understanding the structure-function relationship of salient protein-protein and protein-nucleic
acid interactions. The SBB Core will work closely with the PBE Core in providing superior services to achieve
the optimization of high-quality protein preparations and their characterization. Additionally, with available bio-
physical approaches, namely, isothermal calorimetry (ITC), surface plasmon resonance (SPR), microscale ther-
mophoresis (MST), size exclusion chromatography coupled with multi-angle laser light scattering (SEC-MALS),
and mass photometry (MP), the SBB Core is well positioned to determine the kinetics and thermodynamics of
complex formation, determine subunit structures, and define complex stoichiometries of interactions germane to
helping achieve the objectives of each of the three Research Projects.

Public health relevance
PROJECT NARRATIVE Identification of the structure function relationships of intrinsically disordered proteins are central to understand- ing their biological function in homology directed repair (HDR) of DNA double strand breaks. The Structural Biology and Biophysics Core will provide atomic resolution mapping of critical protein-protein and protein-nucleic acid interactions of complexes important for HDR. The insights provided by the Core will assist Program Project Investigators in dissecting the mechanisms of 53BP1 regulation of 5’ strand resection and the formation of RAD51-ssDNA nucleoprotein fragments, processes important for HDR.